IMPROVED ALLOGRAFT HEART VALVE PRESERVATION

DESCRIPTION (provided by applicant): Cryopreserved allogeneic human heart valves are presently the preferred aortic and pulmonary heart valve prostheses for pediatric patients, women of child-bearing age and non-drug compliant patients. Unfortunately, these valves often deteriorate in younger pediatric patients. The objective of this proposal is development of cryopreservation methods that cause less interstitial damage than methods currently employed for preservation of human heart valves. In Phase I we demonstrated significant interstitial ice in heart valves during "conventional" cryopreservation. Since Phase I we have developed relatively non-cytotoxic methods for molecular ice control resulting in either modified or elimination of ice during cryopreservation. In this Phase II proposal ice control formulations will be screened using assays of structural deterioration, calcification, ice formation, morphology and cell viability using rat or sheep heart valve-derived tissues. The best formulation will be scaled up from small volume tissues to clinical-sized specimens using sheep heart valves and validated for human heart valves. Molecular ice control methods of heart valve preservation will be compared with conventionally cryopreserved valves in an allogeneic sheep model. It is anticipated that modification or reduction of ice formation in cryopreserved valves should decrease the need for reoperation due to structural deterioration and calcification in allograft recipients.